Optimizing Biological Circuits: Methods and Application

[unreadable] DESCRIPTION (provided by applicant): This research seeks to further develop the general framework for optimizing human-engineered biological circuits. Here, mathematical modeling identifies mutational targets for directed evolution. This identification constrains the evolutionary search space, while directed evolution re-engineers the targets without mechanistic or detailed structural information. This proposal advocates using directed evolution to first systematically perturb the mutational target to generate components with a wide range of functionality, then to evaluate circuit behavior for each component. The benefits of this technique are (1) the library of components can be used interchangeably with other circuits, and (2) systematic perturbation permits model validation and refinement. This strategy will be used to examine the Lux quorum-sensing module, which regulates gene expression in bacteria as a function of the population density. Because bacteria thrive in diverse conditions, this technology has potential applications in biosensing and biomedicine. Additionally, characterizing this module should address several fundamental questions: how bacteria regulate cell-cell communication, how the configuration found in nature might have evolved, and whether or not cell-cell communication can coordinate population behavior in the presence of intracellular stochasticity and cell-to-cell variation. [unreadable] [unreadable] [unreadable]